Cerebellar-striatal circuits for control of dopamine activity and food intake

Project Summary
Recently, we identified the cerebellum as a novel satiation center in the brain. Yet, little is known about the
pathways and circuit mechanisms through which the cerebellum regulates food intake. The major research goal
of this proposal is to define cerebellar à striatal circuits that regulate food intake and better understand the
physiological changes mediated by activity in this circuit. We have recently identified a subset of molecularly and
topographically-distinct neurons in the lateral nucleus of the mouse anterior deep cerebellar nuclei (aDCN-lat)
that are activated by food intake (Low et al., 2021). Our functional assessment of these neurons demonstrates
that activation of aDCN-lat neurons dramatically decreases food intake by reducing meal size without
compensatory changes to metabolic rate. We discovered that activity in aDCN-lat neurons reduces the phasic
dopamine response to additional food, likely curbing the urge to eat by reducing the reward value of additional
food (Low et al., 2021). Based on published and preliminary data, the central hypotheses of this proposal are
that: 1) food- and nutrient-sensing aDCN-lat neurons are polysynaptically linked to the striatum through
subcortical pathways to influence striatal dopamine levels, and these neurons have a unique molecular profile
that changes during obesity; 2) aDCN-lat mediated dopamine changes influence neural activity in a subset of
striatal neurons and regulate affective and motivational desire for food; and, 3) aDCN-striatal circuits and DA
signaling are disrupted in obesity. This proposal will test these hypotheses through three aims. Aim 1 delineates
the pathways through which aDCN-lat neurons can act on striatal dopamine and defines transcript changes in
aDCN-lat neurons of diet-induced obese mice. We will use viral tools (AAVretro and rabies) to determine the
intermediate targets of aDCN-lat neurons (hypothesized to be linked by ventral tegmental area and substantia
nigra) and single nuclei RNA-sequencing to identify changes in transcripts of aDCN-lat neurons in obese mice.
In Aim 2, we will examine the influence of aDCN-mediated changes in striatal DA levels on the neural activity of
specific striatal neuron subtypes (D1R and D2R). These experiments will allow us to examine how cerebellar
activity influences the striatal response to food anticipation, consumption and gastric nutrients. Finally, the
experiments in Aim 3 will assess how diet-induced obesity impacts aDCN-mediated changes in striatal neural
activity at a single cell level, and more importantly test the hypothesis that silencing the DCN leads to an ‘obesity-
like’ pattern of neural activity in the striatum. By defining cerebellar-striatal pathways, how cerebellar activity
controls striatal neuron function, and how this circuitry might be disrupted in obesity, this work will reveal circuit
mechanisms that regulate food reward processing with added translational value of guiding the development of
non-invasive cerebellar stimulation and cell-type specific pharmacological manipulation of striatal neurons for
long-term body weight management.

Public health relevance
Project Narrative We recently identified dysfunction in the cerebellum of patients with an extreme excessive eating disorder and found that cerebellar-mediated reward processing potently regulates food intake in mice. This proposal will examine how cerebellar circuits interact with midbrain dopaminergic centers to influence food seeking and consumption. Using intersectional viral tools and single cell sequencing to anatomically and molecularly define the subcortical cerebellar output pathways and deep brain imaging of neural and dopamine activity in diet-induced obese mice, we will define the cerebellar-striatal control of food intake.